Regional specific metabolism regulates specification of the Spemann Organizer

Project Summary
Congenital heart disease is a major cause of illness in newborns and children. While studying Leigh’s
syndrome, a mitochondrial metabolism disease caused by LRPPRC that also causes congenital heart disease
and heterotaxy, we were surprised to discover that regional metabolism in the early Xenopus embryo dictates
cell fate. We found that the Spemann-Mangold Organizer (the Organizer) depends on regional metabolism. In
fact, our work demonstrates that Hif-1α regulates the specification of the Organizer and that the Organizer
consumes 20% more oxygen than more ventral (non-Organizer) tissue. To reconcile an increase in oxygen
consumption and activation of Hif-1α, we discovered that the Organizer has “leak” metabolism, which we have
proposed previously in our group to be caused by the c-subunit of the ATP Synthase. This proposal
investigates a signaling pathway that connects canonical Wnt signaling, Hif-1α, and regional metabolism to
understand an iconic signaling center, the Spemann-Mangold Organizer.

Public health relevance
Project Narrative Congenital heart disease is a major cause of illness in newborns and children. While studying a gene that may cause congenital heart disease, we discovered how cells use energy could affect the type of cell that forms. Our work seeks to understand how a cell uses energy and changes its behavior and fate.